The role of post-traumatic sleep-wake disruption in the development of tau pathology following mild traumatic brain injury

PROJECT SUMMARY
Mild traumatic brain injury (mTBI, concussion) has emerged as a risk factor for the development of
neurodegenerative conditions such as Alzheimer's disease and chronic traumatic encephalopathy, which are
characterized by the aberrant aggregation of tau within neural cells. However, the mechanisms linking mTBI to
tau pathology later in life remain unknown.
The glymphatic system is a recently characterized brain-wide network of perivascular spaces that supports the
rapid exchange of cerebrospinal and interstitial fluid. Glymphatic function contributes to the clearance of both
amyloid beta and tau, and its impairment is believed to underlie their deposition in the aging brain. Glymphatic
pathway function is greatest during sleep and is impaired by traumatic brain injury. Based on these findings,
we hypothesize that that impairment of glymphatic function following mTBI slows the clearance of tau and
contributes to the development of tau pathology following injury. Using a well-established model of repetitive-
blast mTBI, behavioral assessment of cognitive and functional impairment, and histological assessment of tau
pathology in a rodent model of tauopathy, we will characterize glymphatic dysfunction following blast mTBI,
and test whether its impairment promotes post-traumatic tauopathy.
Disruption of the sleep-wake cycle (SWD) is a frequent chronic complaint after mTBI. SWD also accompanies
the development of conditions like Alzheimer's disease in aging populations. More recent clinical and
translational research suggests that SWD may actually promote the development of Alzheimer's-related
pathology, including tau deposition. Based on the common clinical connections between mTBI, SWD, and
neurodegenerative disease, we hypothesize that post-traumatic SWD contributes to the development of
tauopathy following mTBI. Using parallel techniques above, we will define SWD following blast mTBI, and test
whether post-traumatic SWD promotes the development of tau pathology after injury.
In both observational clinical studies and in rodent models, post-concussive symptoms exhibit different
temporal profiles following single or repetitive mTBI. To comprehensively define the role that glymphatic
impairment and sleep disruption play in the development of tau pathology following mTBI, these studies will be
carried out in parallel in mouse models of single and repetitive blast mTBI.
The results of this study may provide a novel perspective on the mechanisms underlying the development of
post-traumatic neurodegeneration, and may support targeting glymphatic pathway function and SWD in the
prevention and treatment of conditions such as Alzheimer's disease in Veteran populations with a history of
exposure to mTBI.

Public health relevance
Mild traumatic brain injury (mTBI), or concussion, has emerged as a potential risk factor for the development of neurodegenerative conditions including Alzheimer's disease. Alzheimer's disease is characterized in part by the buildup of aggregates of the protein tau within cells of the brain. Yet how mTBI may contribute to the development of this tau buildup remains unknown. Disruption of normal sleep-wake patterns is a frequent complaint after mTBI, while in aging populations, sleep disruption appears to promote the development of neurodegenerative pathology. In this study will test whether sleep disruption after mTBI exposure contributes to the development of post-traumatic tau pathology. We will also specifically test whether the dysfunction of the brain's waste clearance system, called the glymphatic system, links mTBI with tau pathology. These studies may pave the way for new approaches to preventing dementing conditions like Alzheimer's disease in both Veteran and civilian populations exposed to mTBI earlier in life.